Do Hair Cortisol and Hair Oxytocin represent the Stressful and Supportive Experiences of Preschool Children?

Early life stress (ELS) can disrupt the development of nervous, cardiovascular, metabolic, and immune
systems, leading to poor physical and mental health throughout the lifespan. The rising prevalence of ELS in
preschool children is a major public health concern, epidemiologically linked with higher rates of youth
suicides, dating violence, drinking, and drug abuse. Individuals respond to acute stress by releasing cortisol;
thus, hair cortisol concentrations (HCC) can quantify the exposures to recurrent or chronic stress in children.
Our pilot data on HCC revealed various factors that are associated with chronic stress in preschool children.
We propose hair oxytocin concentrations (HOC) as a summative measure of supportive and/or socially
affiliative experiences. Specific aims of the proposed study are: (1) to validate novel assays for measuring
HCC and HOC in 1200 preschool children and their parents, in order to quantify their cumulative exposures to
stressful vs. supportive early experiences; and (2) to measure hair growth rates, thereby delineating the time
periods related to such exposures and their hair composition (protein, lipid, water content) to interpret and/or
adjust the HCC and HOC values obtained from the preschool children and their parents.
We will collect hair samples from children ages 1-5 years (n=1200) and at least one accompanying parent
(n=1200). From parents we will obtain their child's demographic, developmental, health and environmental
data. Hair samples will be processed using our novel extraction methods and analyzed using specific enzyme-
linked immunosorbent assays (ELISA) for HCC and HOC; these assays will be validated using tandem mass
spectrometry (LC/MS-MS). We will measure hair growth rates using the standard phototrichogram technique
and hair composition using direct spectrophotometric detection. These data will establish the reference norms
for HCC and HOC in preschool children and their hair growth rates will identify the time periods that these HCC
or HOC values represent.
We will examine the natural variations in HCC, HOC, and hair growth rates in relation to age, sex, race,
ethnicity, parental, socioeconomic, or other environmental factors. HCC and HOC values obtained from the
same hair sample will also allow us to examine oxytocin-mediated regulation of the cortisol responses to ELS.
We have a multidisciplinary team (clinician, psychologist, sociologist, biochemists, statistician), the equipment,
the experience, and pilot data to successfully complete the proposed project. Completion of this research will
provide age-specific reference norms for HCC, HOC, and hair growth rates in healthy preschool children. This
project will address fundamental gaps in our current knowledge and establish a scientific framework to
investigate long-term physical and mental health consequences of early childhood stress, following physical or
psychological trauma, traumatic/toxic stress, violence-related injury, child maltreatment, and acute or critical
illnesses – identified as a high-priority research area by NICHD.

Public health relevance
Project Narrative Early life stressors (ELS) or adverse childhood experiences (ACEs) in preschool children lead to poorer physical and mental health across their lifespan, increasing their risks for chronic non-communicable diseases, substance abuse, and other long-term problems, whereas loving, nurturing experiences in early childhood can build their resilience and improve outcomes from a life-course perspective. By studying healthy preschool children, we will define the normal reference ranges for (1) Hair Cortisol as a biomarker for recurrent or chronic stress in early childhood; (2) Hair Oxytocin as a biomarker for socially affiliative and supportive experiences; and (3) age-specific hair growth rates to delineate the time periods related to these hair cortisol and hair oxytocin values. The proposed studies will address fundamental gaps in our current knowledge and establish a scientific framework to investigate the lifespan effects of early childhood stress, including the long-term physical and mental health consequences of early childhood stress, following physical or psychological trauma, violence-related injury, child maltreatment, traumatic or toxic stress, or critical illnesses in early childhood.